Structural profiling of tauopathy seeds

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease and other tauopathies are tau protein conformation diseases that impact millions of people.
There is currently no means to diagnose patients based on tau conformation. The microtubule associated protein
tau can convert into distinct pathogenic shapes each causing different human diseases. High-resolution cryo-
Electron Microscopy structures of tau fibrils isolated from different diseases reveal the diversity of structures that
tau can adopt in each disease. Fibril structures highlight the central role of amyloidogenic motifs forming
stabilizing nonpolar contacts to determine the distinct folds. Our model predicts that the propensity of a tau
monomer to adopt structural polymorphs is linked to perturbation of local structures that expose different patterns
of amyloidogenic motifs. Detection of tauopathy-derived tau conformations will be essential to develop accurate
disease diagnoses. To understand the structure and origins of tau amyloid assembly in tauopathies, we propose
to: (i) develop predictive algorithms for tau structure based on functional genetics, (ii) test role of local motifs in
control of tau assembly, (iii) test role of pathogenic mutations on local structure. We anticipate that our approach
will allow diagnosis of tauopathies based on tau conformation in premortem, and possibly presymptomatic,
patients samples, and also provide fundamental insight into the rules that govern tau assembly in disease. Our
long-term goal is to develop diagnostic and therapeutic approaches to treat neurodegenerative diseases. This
project is in alignment with the mission of the NIA to support biological and clinical research on aging.

Public health relevance
PROJECT NARRATIVE The tau protein deposits in the brain of Alzheimer’s patients. The tau protein normally adopts a “good” shape and with age converts into different “bad” shapes. We aim to understand how tau changes into “bad” shapes to help understand how to detect these species in patients and develop therapies to prevent them.